Elucidating Regulatory Mechanisms of Lamin B1 Expression in Autosomal Dominant Leukodystrophy

Abstract
Autosomal Dominant Leukodystrophy (ADLD) is a fatal, adult onset, progressive neurological disease that is
characterized by widespread CNS demyelination. Most cases of ADLD are caused by tandem genomic
duplications (ADLD-dup) involving the lamin B1 gene (LMNB1) while a small subset is caused by genomic
deletions upstream of LMNB1 (ADLD-del). Both these mutations are thought to cause increased CNS LMNB1
expression and are a 100% penetrant i.e., all individuals with the mutation develop the disease. LMNB1 is a
component of the nuclear lamina and plays a critical role in maintaining nuclear architecture, regulating gene
expression and modulating chromatin positioning. Why increased expression of a widely-expressed gene such
as LMNB1 causes such a specific demyelination disorder is unknown.
Using a combination of patient data, murine and human derived oligodendrocyte (OL) lineage cells we propose
to test the hypothesis that genomic rearrangements involving Lamin B1 that cause ADLD result in mis-expression
of the lamin B1 gene. We will identify regulatory elements and mechanisms that can potentially regulate Lamin
B1 expression both in vitro and in vivo using a novel mouse model.
The experiments we have proposed will allow us to comprehensively characterize a potentially novel OL
regulatory element that can provide mechanistic insights into the tissue type specificity of ADLD and the role of
non-coding regulatory elements in OL function and demyelinating diseases.

Public health relevance
Project Narrative An increase in the amount of a protein called lamin B1 in the brain occurs in a disease known as Autosomal Dominant Leukodystrophy (ADLD) causing loss of myelin (a fatty substance covering nerves) and leading to muscle wasting, weakness and early death. Why more of lamin B1, a protein expressed in many different tissues, specifically causes demyelination is unknown. This proposal aims to understand the mechanisms that cause the specificity by characterizing elements that regulate the expression of this gene both in cells and mouse models.